Nerve-Specific Fluorophores for Improved Nerve Sparing during Prostatectomy using the Clinical Fluorescence Guided Surgery Infrastructure

PROJECT SUMMARY
Iatrogenic nerve injury represents one of the most feared surgical complications and remains a major morbidity
across all surgical specialties. Nerve-sparing radical prostatectomy is a compelling clinical example of significant
patient morbidity, where nerve damage is reported in up to 60% of patients resulting in incontinence and impo-
tence. Surprisingly, no clinically approved technology can enhance intraoperative nerve visualization, typically
performed through neuroanatomical knowledge and conventional white light visualization alone. Development
of a near infrared (NIR) fluorophore that specifically highlights nerve tissue in the operating room would have
direct clinical translation to nerve sparing prostatectomy through the FDA approved fluorescence channel in the
da Vinci surgical robotic system (Firefly, Intuitive Surgical, Inc.), which is used in >80% of prostatectomies per-
formed in the United States today. The proposed work will directly address this unmet clinical need. Fluorescence
Guided Surgery (FGS) has successfully integrated into clinical medicine with only two FDA-approved NIR fluor-
ophores (i.e., indocyanine green [ICG] and methylene blue). FGS systems operate almost exclusively in the NIR
(700-900 nm), where tissue chromophore absorbance, autofluorescence and scatter fall to local minima, allowing
high contrast and high resolution imaging at up to centimeter depths. All clinical FGS systems have an “800 nm”
channel designed to image ICG. To facilitate rapid clinical translation, the overall goal herein is to generate a
nerve-specific small molecule fluorophore with spectral properties matched to ICG, enabling both nerve imaging
at depth and future clinical translation using existing clinical FGS infrastructure. Design and development of a
small molecule nerve-specific fluorophore that can be imaged using FGS systems optimized for ICG has been
a significant challenge because these probes need to have a low enough molecular weight to cross the tight
blood nerve barrier junction with a sufficient degree of conjugation for NIR excitation and emission. In exciting
preliminary work, our team has synthesized first-in-class NIR nerve-specific small molecule fluorophores that
can be imaged with standard FGS systems optimized for ICG. Herein, these novel probes will be synthetically
tuned and validated for clinical utility through translation to swine and canine models using the da Vinci as well
as completion of preclinical pharmacology and toxicology (pharm/tox) studies, enabling a future IND application
to the FDA for clinical translation to robotic assisted radical prostatectomies (RARP). This goal will be accom-
plished through the following specific aims: Aim 1: Synthetic tuning and characterization of NIR nerve-specific
fluorophores for future clinical FGS. Aim 2: Demonstrate compatibility with the da Vinci Firefly and preclinical
pharm/tox suitable for clinical translation. Aim 3: Select the optimal 800 nm, nerve-specific fluorophore for future
clinical translation to guide nerve-sparing RARP. Successful completion of this R01 will result in an optimal NIR
nerve-specific fluorophore suitable for use with all clinical FGS systems and validation of nerve-specific contrast
for RARP using the da Vinci Firefly.

Public health relevance
PROJECT NARRATIVE Nerve-sparing radical prostatectomy is first line therapy for localized prostate cancer, however preservation of the surrounding nerve tissue continues to challenge surgeons and leaves up to 60% of patients with some form of incontinence and impotence post-surgery. Nerve visualization in the operating room is difficult and no clinically approved imaging methodology has been developed to aid in nerve identification and visualization. In the work proposed herein, we will develop a clinically relevant near infrared nerve-specific imaging strategy to be utilized with the FDA approved fluorescence-imaging channel in the da Vinci surgical robot enabling nerve-specific imaging during robotic assisted nerve-sparing radical prostatectomy for improved surgical outcomes.